Chemical Inhibitors of CREB-mediated Gene Transcription

DESCRIPTION (provided by applicant): The goal of the proposed research is to develop small molecule inhibitors of CREB (cAMP-response element binding protein)-mediated gene transcription as potential anticancer agents. Recently, accumulating evidence has revealed that CREB participates in the regulation of immortalization, transformation and metastasis of cancer cells. In some cancer patients (e.g. acute leukemia, prostate cancer and breast cancer), expression of CREB correlated with cancer phenotypes including cancer cell differentiation, metastasis, time to relapse and survival. This suggests that inhibiting the transcription activity of CREB could be a promising strategy for anticancer treatment. Consistent with this hypothesis, expression of a dominant-negative CREB mutant in melanoma and lung cancer cell lines or down-regulating the expression of CREB in leukemia cell lines reduced the transforming phenotypes of the cancer cells. Moreover, delivery of a CRE decoy oligonucleotide into human breast cancer or prostate cancer cells led to significant inhibition of tumor cell growth both in vitro and in vivo while similar experiments in normal cells showed no toxicity. These results indicate that pharmacologically inhibiting CREB activity could be an excellent strategy for cancer treatment. However, small molecule inhibitors of CREB-mediated have not been developed for evaluation of anticancer activity. We recently developed a novel assay to specifically look at CREB-CBP interaction and discovered naphthol AS-E as a small molecule inhibitor of CREB-CBP interaction both in vitro and in cells. Moreover, we found that this compound was able to inhibit cancer cell growth by inducing apoptosis in a number of different cancer cells irrespective of their p53 status. Based on these promising preliminary results, we propose to further evaluate its therapeutic potential and optimize its anticancer activity. The following aims will be addressed: 1) To define the structure-activity relationships (SAR) of naphthol AS-E as an anticancer agent and inhibitor of CREB-CBP interaction by designing and synthesizing analogs with different substitutions on the appendant phenyl ring; 2) To develop a novel series of naphthol AS-E derivatives with enhanced potency and aqueous solubility as probes for structural studies; 3) To investigate the hypothesis that CREB-mediated gene transcription is required for anticancer activity displayed by naphthol AS-E and its derivatives. Development of small molecule inhibitors CREB-mediated gene transcription will not only lead to potential therapeutics for cancer, but also provide a powerful tool to manipulate CREB's activity in vitro and in vivo to further dissect its biological functions.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is to develop chemical inhibitors of CREB-mediated gene transcription. These inhibitors are expected to be potential candidates as anticancer agents for a variety of cancers. Project Narrative: The proposed research is to develop chemical inhibitors of CREB-mediated gene transcription. These inhibitors are expected to be potential candidates as anticancer agents for a variety of cancers. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS The goal of the proposed research is to develop small molecule inhibitors of CREB (cAMP-response element binding protein)-mediated gene transcription as potential anticancer agents. CREB is a transcription factor known to be a critical regulator of cell proliferation and survival in normal neuronal development. Recently, accumulating evidence has revealed that CREB participates in the regulation of immortalization, transformation and metastasis of cancer cells. In some cancer patients (e.g. acute leukemia, prostate cancer, breast cancer and lung cancer), expression of CREB correlated with cancer phenotypes including cancer cell differentiation, metastasis, time to relapse and survival. This suggests that inhibiting the transcription activity of CREB could be a promising strategy for anticancer treatment. Consistent with this hypothesis, expression of a dominant-negative CREB mutant in melanoma and lung cancer cell lines or down-regulating the expression of CREB in leukemia cell lines reduced the transforming phenotypes of the cancer cells. Moreover, delivery of a CRE decoy oligonucleotide into human breast cancer or prostate cancer cells led to significant inhibition of tumor cell growth both in vitro and in vivo while similar experiments in normal cells showed no toxicity. These results indicate that pharmacological inhibition CREB's transcription activity could be an excellent strategy for cancer treatment. However, small molecule inhibitors of CREB-mediated gene transcription have not been developed for evaluation of anticancer activity. Transcriptional activation by CREB requires its phosphorylation and binding with CBP (CREB-binding protein). This binding interaction is mediated by KID (kinase-inducible domain in CREB) and KIX (KID-interacting domain in CBP). We recently developed a novel renilla luciferase complementation assay to monitor KIX-KID interaction. Using this assay, we discovered naphthol AS-E as a novel small molecule inhibitor of KIX-KID interaction and CREB-mediated gene transcription. Furthermore, we found that it was able to inhibit cancer cell growth by inducing apoptosis in a number of different cancer cells irrespective of their p53 or efflux pump p-glycoprotein status. Based on these promising preliminary results, we propose to further evaluate its therapeutic potential and optimize its anticancer activity as an inhibitor of KIX-KID interaction. The following Specific Aims will be addressed: 1) To define the structure-activity relationships (SAR) of naphthol AS-E as an inhibitor of KIX-KID interaction and an anticancer agent. Our preliminary results show that naphthol AS-E displays selective cytotoxicity against cancer cells. The major effort of this aim will be directed toward design and synthesis of novel analogs of naphthol AS-E with different substitutions at the appendant aniline ring. Conformationally restrained analogs will also be designed and synthesized. Design of novel analogs is facilitated by our molecular binding model of naphthol AS-E to KIX. The biological activities to be investigated include KIX-KID interaction, cancer cell cytotoxicity and CREB-mediated reporter gene transcription inhibition. Selected compounds with promising in vitro biochemical and cellular activity will also be examined for in vivo anticancer activity and untoward toxicity. 2) To develop a novel series of naphthol AS-E derivatives with 2'-substitution as probes for structural biology studies and as anticancer agents with enhanced potency. This is based on our binding model and preliminary studies showing that 2'-substituted naphthol AS-E derivatives display enhanced inhibitory potency towards KIX-KID interaction. Studies in this aim will be to design novel analogs to target additional amino acid residues in KIX to enhance its inhibitory activity and aqueous solubility. Additionally, probes for potential covalent labeling of KIX will be designed. These ligands will also be used for NMR structural studies in addition to the biological activities presented in Aim #1. Selected compounds with promising in vitro biochemical and cellular activity will also be examined for in vivo anticancer activity and untoward toxicity. Further studies are proposed to map the ligand binding site on KIX. 3) To investigate the hypothesis that CREB-mediated gene transcription is required for the anticancer activity displayed by naphthol AS-E and its derivatives. Our preliminary results demonstrate that overexpression of a constitutively active CREB mutant is able to reverse the cell death induced by naphthol AS-E. This suggests that inhibition of CREB-mediated gene transcription by naphthol AS-E is sufficient to induce cancer cell death. We will further investigate the hypothesis that naphthol AS-E and its derivatives induce cancer cell death by inhibiting CREB-mediated gene transcription with different CREB mutants in cancer cells. The expression of potential CREB target genes will be evaluated. In addition, we will also study the specificity of the compounds using a variety of different strategies.